CONTROLLED STUDY OF PHOTOTHERAPY FOR NEONATAL HYPERBILIRUBINEMIA

This study, which began in 1974, is a cooperative, randomized clinical trial to determine the safety and efficacy of phototherapy for treatment of neonatal hyperbilirubinemia by comparing phototherapy with non-phototherapy infants under specific conditions. Babies were randomized by weight (less than 2,000, 2,000 - 2,499 and greater than 2,499 grams) to the phototherapy or non-phototherapy groups. Infants, 2,000 grams and above, were admitted to the study when their bilirubin reached levels specified in the study protocol. All infants under 2,000 grams were admitted. Physical, neurological and mental development of these infants were followed through six years of age. The Biometry Branch served as a data center for this study and was the focal point for receipt of examination forms. The master files for each year's follow-up were edited for keypunch and coding errors and for internal consistency. The Branch is now analyzing the data in cooperation with the principal investigators from the cooperating units. The results of the newborn data were published in a supplement to Pediatrics in February 1985. It is anticipated that manuscripts on the follow-up data will be submitted for publication by the end of 1987.